Penn PET Addiction Center of Excellence (PACE)

ABSTRACT/SUMMARY
Opioid use disorder (OUD) is a public health emergency due to the increasing opioid overdose (OD)-related
deaths and non-fatal morbidity rate. OD results in severe respiratory depression and hypoxic ischemia, which
can damage brain areas sensitive to reduced oxygenation (e.g., the hippocampus) and thereby impair
neurocognitive functioning. There is ample evidence of Alzheimer's disease-like pathology, i.e.,
hyperphosphorylated tau and amyloid precursor protein, in the post-mortem brain tissues of individuals with
OUD. The neurocognitive impairments in OUD and/or after non-fatal OD may reflect incipient dementia –
contributing to poor outcomes, including OUD treatment resistance. Alternatively, OUD and/or non-fatal OD may
be independent risk factors for Alzheimer's disease. To date, no studies have evaluated the effects of non-fatal
ODs or chronic opioid exposure on tau deposition in humans in vivo. Thus, the central aim of this proposal is to
investigate the effects of non-fatal OD and chronic opioid exposure on Alzheimer's disease-like pathology: brain
tau deposition, brain morphology, and brain responses during memory encoding on a visual episodic memory
task using PET/CT and MRI imaging. Three groups of 5 individuals (total N=15) will be recruited: one group with
OUD will have a history of at least one
of
OD in the past year (OUD/OD+), one group with OUD will have no history
OD (OUD/OD-), and one group will comprise non-dependent healthy control individuals (HC). All groups will
undergo a tau PET/CT brain scan with [18F]PI-2620, a brain structural MRI scan, and a visual episodic memory
task-based functional MRI scan, for which performance has been shown to be impaired in both OUD and
Alzheimer's disease. In Aim 1, we will test the hypothesis that the OUD/OD+ group has greater brain tau
deposition than the OUD/OD- and HC groups, indicative of the pathological effects of hypoxic-ischemic injury
after OD. In Aim 2, we will test the hypothesis that OUD/OD+ individuals have smaller hippocampal gray matter
volume than the OUD/OD- and HC groups. In Aim 3, we will test the hypotheses that OUD/OD+ individuals have
impaired behavioral performance and hippocampal activation on a visual episodic memory task compared to the
OUD/OD- and HC groups, and that hippocampal/entorhinal cortical [18F]PI-2620 binding will covary with
hippocampal activation. Successful completion of this study will enable us to estimate effect sizes and power for
the design of a definitive study of whether a history of non-fatal OD and/or chronic opioid use are associated
with Alzheimer's disease-like pathology. The proposed set of studies will help to elucidate the pathophysiological
basis for cognitive impairments in individuals with OUD and improve our understanding of the contribution of
chronic opioid use and OD on cognitive performance. Study findings could aid in the selection of novel treatment
approaches aimed at brain recovery and relapse prevention in OUD and provide a method to monitor changes
in pathologic effects over time associated with Alzheimer's disease risk.

Public health relevance
PROJECT NARRATIVE The proposed P30 supplement research represents the first systematic attempt to examine Alzheimer's disease- like brain pathology in vivo in individuals with opioid use disorder (OUD) differentiated by a history of opioid- related overdose. This work will provide critical insights into effects of non-fatal opioid overdose and OUD on the development and cognitive impairment. The new knowledge obtained could help to develop time-sensitive intervention efforts that mitigate the long-term adverse effects of non-fatal overdose on neuropathology and neurocognition in OUD, and elucidate of tauopathy, neurodegeneration, the contributions of OD and OUD-related neuropathologyto dementia risk.